Independent and joint effects of volumetric breast density and body mass index to identify women at high risk of breast cancer

Project Summary The long-term goal of this project is to understand the relationship between obesity and volumetric breast density, and use this knowledge to better identify women at high risk of breast cancer and optimize resource allocation for intervention. Breast density is widely accepted as one of the strongest risk factors for breast cancer, and new automated measurements of breast density have facilitated the increasing use of breast density in the clinical setting for risk prediction and risk-based screening. It is plausible that other breast cancer risk factors modify the effect of breast density on breast cancer, and assessing this question using new fully- automated measures of breast density is important as these measures have the potential to be fully-integrated into clinical settings. Obesity is one of the most common risk factors for breast cancer among women in the United States, and there are likely to be a large number of overweight and obese women with high breast density. It is biologically plausible that the joint effect of obesity and breast density on the breast microenvironment may put women with both conditions at increased risk of breast cancer. The objective of this proposal is to characterize the effect of BMI on volumetric measures of breast density among premenopausal and postmenopausal women (Aim 1), and evaluate if body mass index (BMI) modifies the effect of volumetric breast density on breast cancer risk such that obese women with high breast density are at highest risk (Aim 2). These aims will provide a critical understanding of the complex relationship between obesity, breast density and breast cancer risk among premenopausal and postmenopausal women. The assessment of interaction on both additive and multiplicative scales will ensure that our results have high relevance to understanding potential mechanisms of interaction and identifying subgroups of women that may benefit the most from intervention to reduce breast density or BMI, two readily modifiable risk factors. The interdisciplinary training environment for this proposal will provide the applicant the opportunity to gain technical skills, build research competency and develop content area expertise to further her career as a future independent researcher.

Public health relevance
Project Narrative Mammographic breast density is one of the strongest risk factors for breast cancer is increasingly used in the clinical setting for breast cancer risk stratification. It is unclear if the effect of breast density on breast cancer risk is similar among overweight and obese women, a growing subpopulation of women in the United States, compared to leaner women. This study uses novel volumetric breast density measures to assess the effect of body mass index (BMI) on volumetric breast density, and determine if obesity modifies the effect of dense volume on breast cancer. Our results will provide a better understanding of the relationship between obesity, breast density and breast cancer risk among premenopausal and postmenopausal women, and may identify subgroups of women who will benefit the most from targeted screening and intervention efforts.